The roles of anesthetics and neuroimmune interactions in postoperative cognitive dysfunction

Project Summary
Postoperative cognitive dysfunction (POCD) is common in elderly patients after major surgery. As the
population of geriatric surgical patients grows, it is imperative to understand the pathogenic mechanisms
underlying POCD and develop treatment strategies. Accumulating evidence suggests that general anesthetics
administered during surgery at the extremes of age could have long-lasting detrimental effects on the nervous
system. Indeed, our studies of cortical circuits have revealed various undesired effects of general anesthesia
on both developing and aging brains after surgery, including changes in synaptic protein, abnormal dendritic
spine plasticity and neuronal function, as well as impaired neurocognitive performance. These anesthesia-
induced changes in neuronal plasticity and function could have an important role in the development of POCD,
particularly in aging individuals. In addition to anesthetic drugs, immune cells and signaling pathways activated
after surgery may also have profound impacts on brain functions and contribute to POCD. Using in vivo
longitudinal imaging of neuronal structure and function, we will first determine how general anesthesia leads to
long-lasting changes in neuronal circuits and the delayed neurocognitive recovery after surgery. Combined
with an immunological toolset including bone marrow chimera, in vivo cell depletion and adoptive cell transfer,
we will further determine the neuroimmune mechanisms mediating neural circuit dysfunction in POCD. We will
also manipulate neurotransmission and immune signaling pathways to facilitate postoperative cognitive
recovery. Together, our proposed experiments will likely reveal the important functions of anesthesia and
immune activation in POCD and help the development of therapeutic treatment.

Public health relevance
Project Narrative Postoperative cognitive disturbances are common in elderly patients who have undergone general anesthesia and surgery. This project will investigate the precise roles of anesthetics and the innate immune system in surgery-associated brain alterations in animal models of postoperative cognitive dysfunction. The proposed experiments will provide important mechanistic insights into neurocognitive impairment associated with anesthesia and surgery and help the development of new treatment strategies.